IGF::OT::IGF KAISER DIVISION OF RESEARCH WILL PROVIDE THE OVERALL MANAGEMENT, INTEGRATION AND COORDINATION OF ALL CONTRACT ACTIVITIES, INCLUDING THE MANAGEMENT AND COORDINATION OF ACTIVITIES CARRIED O

alcohol